Adaptive statistical algorithms for learning and control of neural dynamics

Adaptive statistical algorithms for learning and control of neural dynamics
Project Summary / Abstract
The lack of real-time and closed-loop machine learning tools limits experimentalists from investigating learned
behavior and neural dynamics. Real-time and closed-loop methods can bring about new experimental investi-
gations aimed at understanding neural information processing at the system and organism levels. They allow
experimentalists to monitor the animal's internal states and probe their internal dynamics to infer the animal's
information processing architecture. To this end, we develop real-time adaptive algorithms for modeling nonlinear
dynamical systems, feedback control strategies, and adaptive behavior training algorithms. Compared to ofﬂine
data analysis, real-time and closed-loop experiments are more challenging from a statistical machine learning
perspective. Typically these algorithms have many tunable knobs that cannot be changed during the experimen-
tal session, and repeating the same experiment with different settings is orders of magnitude more expensive than
re-analyzing data ofﬂine. To overcome this difﬁculty and address potential convergence speed issues, we pro-
pose to exploit the commonalities across animals, recording sessions, and datasets from different tasks through
hierarchical modeling and meta-learning to ﬁnd the best parameters for each experiment. Although the exact set
of parameters may not be similar, we can learn hyper-priors that can smooth over datasets and meta-learn to
learn faster from streaming data (Aim 1). We also propose to further reﬁne the implementations of our algorithms
and branch out to more challenging complex behaviors. Speciﬁcally, we will use deep-learning in loop adaptive
experimental design with the aim to (1) ﬁnd the optimal stimulus to train deep neural networks to predict neural
response, (2) synthesize best images to train an interpretable deep neural network model, and (3) train models
using natural and perturbed behavior (Aim 2). Finally, we propose to improve the robustness and stability of the
real-time data analysis pipeline to enhance the quality of the closed-loop experiments (Aim 3).

Public health relevance
Project Narrative We will develop new tools to learn faster from experimental data to understand the inner workings of animal brains. These tools will bring about efficiency and open new avenues for causal manipulations of internal states over time while the animal is engaged in simple behavioral tasks.